National Longitudinal Mortality Study (NLMS)

The Census Bureau will link the National Longitudinal Mortality Study to the SEER November 2013 submission file research dataset and develop an analytical file for research purposes.